eSTEP: An integrated mHealth intervention to engage high-risk individuals along the full PrEP care continuum

Pre-exposure prophylaxis (PrEP) is highly-effective in preventing new HIV infections among gay, bisexual and
other men who have sex with men (GBMSM) and transgender women (TW), but relies on engaging these high-
risk communities at multiple steps along the PrEP continuum of care. Studies show that a minority of PrEP-
eligible GBMSM are taking PrEP, and TW are less likely than GBMSM to have heard of PrEP, talked with their
provider about PrEP, used PrEP in the past 6 months, and been adherent to PrEP. An existing HIV testing and
PrEP program led by members of our study team in San Diego, CA found that over 60% of GBMSM and TW
participants eligible for PrEP were not interested in starting it; of those who did start PrEP, only 5.8% remained
on PrEP after 3 months. Clearly, innovative interventions that optimize the PrEP continuum of care for diverse
GBMSM and TW are needed. We propose here a theoretically-grounded (in the IMB model), effective, accessible
and sustainable mHealth PrEP care continuum intervention for GBMSM and TW, called eSTEP (Electronic
Support To Engage with PrEP). The eSTEP WebApp will be tailored by sexuality and gender status and include
a set of interactive components delivered before in-person HIV testing (e.g., PrEP information on the benefits of
PrEP) and after the participant tests HIV-negative and agrees to start PrEP (e.g., adherence self-monitoring).
Aim 1: Use an iterative development process to gain feedback on eSTEP content and features through
focus groups with GBMSM and TW and a community advisory board (CAB). 6 focus groups with 18-45
year-old GBMSM and TW (6 participants/group; > 50% Black/Latinx) will be conducted at 3 key points in the
intervention development cycle to create the tailored (separately for GBMSM & TW) IMB-related content and
features of eSTEP. A CAB of GBMSM (n=3) and TW (n=3) will be established to provide guidance between
rounds of focus groups. Aim 1 will culminate in usability testing among 3 GBMSM and 3 TW to finalize eSTEP.
Aim 2: Conduct a pilot randomized controlled trial of eSTEP to assess its feasibility, acceptability, and
preliminary impact among GBMSM and TW in preparation for a large-scale R01. 120 (50% racial/ethnic
minority) GBMSM (n=85) and TW (n=35) who report risk factors that qualify for PrEP eligibility will be randomized
(2:1) to the eSTEP intervention (n=80) or a usual HIV testing control (n=40). The eSTEP group will have
immediate access to pre-HIV testing components. All study participants will be offered free in-person HIV testing
and, if eligible, PrEP at a university-based HIV prevention and treatment clinic. eSTEP participants who begin
PrEP will unlock PrEP adherence and persistence components. Follow-up study visits will be conducted at 3-
and 6-months to collect biological, clinical, and self-reported outcomes to assess eSTEP’s feasibility,
acceptability, and preliminary outcomes (HIV test completion, PrEP initiation, PrEP adherence, and PrEP
appointment attendance). Finally, 10 GBMSM and 10 TW in the intervention arm will participate in an exit
interview to gain feedback on eSTEP in anticipation of a large-scale R01 study.

Public health relevance
We propose here a theoretically-grounded (in the IMB model), accessible and sustainable mHealth PrEP care continuum intervention for gay, bisexual, and other men who have sex with men (GBMSM) and transgender women (TW), called eSTEP (Electronic Support To Engage with PrEP). The eSTEP WebApp will be tailored by sexuality and gender status and include a set of interactive components delivered before in-person HIV testing (e.g., PrEP information on the benefits of PrEP) and after the participant tests HIV-negative and agrees to start PrEP (e.g., adherence self-monitoring). If feasible and acceptable, eSTEP will be the first scalable mHealth intervention that addresses the full PrEP continuum of care for GBMSM and TW to help reach the End the HIV Epidemic goal of substantially reducing new HIV infections in the US.